Quantification of Distraction in Academic settings: A Translational Approach

Distractibility poses a significant public health concern for our youth, due to the seemingly never-ending
barrage of visual and auditory stimulation in our real-life and digital environments. The influx of texts and social
media alerts, traffic, and near peer discussions can interfere with their ability to sustain on-task attention. This
challenge is further compounded by internal distractions such as mind wandering and ruminations. For youth,
distractibility takes its heaviest toll in academic situations, whether in the classroom or when studying at home.
However, traditional metrics of distractibility, from the clinic or laboratory, tend to be broad based or lack
contextual information limiting their ability to predict real-life performance. We propose to use three innovative,
state-of-the-art approaches to enhance the measurement of distractibility to better capture what youth
experience in learning situations. We will apply a Research Domain of Criteria (RDoC) framework, with the
goal of improving understanding of Attention in the RDoC Cognitive System Domain and how the Distractibility
subfactor manifests in varying degrees across naturalistic learning contexts. We will study distractibility in
neurotypical (NT) adolescents and youth with varying degrees of impairing distractibility, including those with
diagnosable Attention-Deficit/Hyperactivity Disorder (ADHD). Our translational team from UC Davis and Bar
Ilan University will assess distractibility, using different methods, across three naturalistic learning
environments: 1) a Virtual Reality (VR) classroom using real academic tasks, while capturing eye-gaze and
behavioral performance; 2) a Live Real classroom, using mobile EEG to measure neural processing and
observing behavioral manifestations of distraction; and 3) throughout the course of students' real-life
learning activities, both at school and during homework, using ecological momentary assessment (EMA) of
attention. As the RDoC framework recommends, we are examining distractibility across multiple units of
analysis including multi-informant (self, parent, teacher) behavioral ratings, self-report live ratings (EMA),
behavioral performance, eye gaze, neural activity and a variety of functional measures related to learning and
executive functioning. The UC Davis team will study adolescents recruited to represent a dimension of
attentional functioning from NT through ADHD. The Bar Ilan research team is embedded in a high school and
will recruit “natural cohorts” of typical high-school students (9th grade), representative of the general population.
We will assess how our measures predict real-life functioning and distinct attentional profiles (subgroups) of
attentional challenges using latent profile analyses within these heterogeneous samples. This innovative,
translational and cross-cultural collaboration will greatly advance our understanding and measurement of
distractibility in ecologically-relevant circumstances. Results will inform the development of measures for the
clinic and laboratory and precision interventions to mitigate distractibility's adverse effects on youth's everyday
functioning, bridging the translational gap between research, clinical practice, and educational activities.

Public health relevance
Distractibility poses a public health concern, impacting accident rates, productivity, and youth's academic performance. High distractibility correlates with adverse outcomes such as lower graduation rates, occupational success, income, and increased anxiety, depression and other severe mental health challenges for adolescents. This innovative project aims to quantify distraction and its effects in real-world learning contexts, enhancing our understanding of individual differences in adolescent distractibility and positioned to inform precision interventions for those significantly impaired in daily functioning.